REGULATION OF CAPILLARY HEMODYNAMICS BY THIN-STRANDED PERICYTES

PROJECT SUMMARY
Capillaries are the sites of gas exchange between circulating red blood cells (RBCs) and the surrounding
tissue. Pericytes are perivascular mural cells and play a vital role in regulating blood flow within the
microvasculature. Based on their general morphology, contractile kinetics, and location along the capillary tree
pericytes can be categorized into different subtypes. Ensheathing pericytes are found on the most arteriole-
proximate segments of the capillary network, have multiple densely-packed enwrapping projections, and can
dynamically constrict capillary vessels. Thin-stranded pericytes are found deeper in the capillary network, have
long, thin processes that extend 100-200 microns from the cell body, and have fewer and smaller capillary
enwrapping projections. Preliminary data presented here show that thin-stranded pericytes are capable of a
constriction in response to increasing intraluminal pressure but through an unknown mechanism. In the current
application, we propose to characterize the ion channels, intracellular signaling pathways, and contractile
machinery responsible for generating the slow pressure-induced focal constrictions by thin-stranded capillary
pericytes. In addition, we will test the hypothesis that the long extending processes of thin-stranded pericytes
function to sense changes in intraluminal pressure and neuronal activity and are capable of generating and
propagating electrical signaling back to the cell body to stimulate constriction. Lastly, we will determine whether
this process is essential for tuning the transit time of flowing RBCs with the capillary network; a process that
facilitates the local release of O2 at specific points within capillary networks. To address these hypotheses, we
will employ our newly developed ex vivo pressurized retina preparation, an application ideally suited for
studying pericyte-dependent constriction of capillary vessels, with several other state-of-the-art approaches,
including advanced optical imaging, electrophysiology, optogenetic stimulation, and genetically engineered
mice. Completion of the proposed work will address many of the controversies in the field, provide valuable
insights into pericyte physiology and identify new therapeutic targets for the regulation of capillary blood flow.

Public health relevance
PROJECT NARRATIVE As the smallest vessels in the circulatory system, capillaries networks, which are made up of endothelial cells and pericytes, are the sites of gas and nutrient exchange between the vasculature and surrounding neurons of the brain. With three morphologically-distinct subtypes of pericytes, the current proposal aims to study a novel role for thin-stranded pericytes in neurovascular coupling, a process linking fluctuations in neural activity with changes in the directed delivery of O2 and nutrients. Completion of the proposal will provide insights into the active role capillaries play in ensuring that O2 is delivered to active neurons and possibly uncover new molecular targets for therapeutic intervention for cardiovascular and neurodegenerative diseases.